Core A: Leadership and Administrative

PROJECT SUMMARY/ABSTRACT
The Leadership and Administrative Core (LAC) will serve to integrate and enhance the research conducted by
the Pacific Northwest Prostate Cancer SPORE Projects and Cores – as well as the faculty supported through
both the Career Enhancement and Developmental Research Programs – through the application of general
administrative support and the facilitation of communication and data dissemination.
The Core will also provide formal links between the following entities:
(1) All investigators comprising the Pacific Northwest (PNW) SPORE in prostate cancer;
(2) Advisory Panels (e.g., External Advisory Board [EAB], Internal Advisory Board [IAB], etc.);
(3) The institutions (e.g., FHCC and other SPORE participatory sites) with laboratories
and clinical facilities wherein occur the research and education components of the SPORE; and
(4) Representatives of the National Cancer Institute (NCI).
This Leadership and Administrative Core has the following Specific Aims:
Specific Aim 1: To provide the organizational structure, based on a group of interacting committees, for
supporting and evaluating the key objectives of the PNW Prostate Cancer SPORE.
Specific Aim 2: To provide oversight of all SPORE activities involving the independent research projects, the
Career Enhancement Program (CEP), the Developmental Research Program (DRP), the
shared resource cores, and the parent institutions.
Specific Aim 3: To organize and coordinate forums for interactions of the Executive Committee, Internal
Advisory Board, and External Advisory Board.
Specific Aim 4: To provide efficient and effective fiscal management of SPORE grant funds.
Specific Aim 5: To communicate and consult with the NCI Project Officer(s) and staff in the preparation of
required progress reports, publications lists, and regulatory documents.
Specific Aim 6: To develop and maintain virtual mechanisms that efficiently facilitate multi-institutional, intra-
and inter-SPORE interactions.